Peer Helping, Retention, and Relapse in Sober Living Houses

Sober living houses (SLHs) are alcohol- and drug-free living environments for persons attempting to
abstain from substances and develop a long-term program of recovery. Studies have shown residents
in these homes make significant, sustained improvements in multiple areas of functioning, including
abstinence from alcohol. One of the strongest and most consistent predictors of relapse is shorter
retention in the house. Focus groups with SLH managers suggest peer helping enhances retention,
commitment to the household, and commitment to recovery. Building upon an ongoing longitudinal
study of SLHs, the proposed study will assess the relative impact of helping behaviors on retention,
and in turn, on relapse. Initial aims will assess how relapse is affected by helping broadly conceived,
including comparisons of giving versus receiving help and helping in relation to peers versus others
(i.e., family and friends). We will also assess how relapse is affected by giving and receiving different
types of help, such as instrumental versus emotional. The study will then test a novel path model
suggesting that, because of the overarching culture of SLHs and the innate benefits of helping in
recovery, helping others in recovery-related contexts (i.e., in the residence and in 12-step groups) will
lead to stronger relationships with peers in recovery, improved self-esteem, a stronger commitment to
abstinence, more focus on others, and improved recovery-related coping skills. We posit all of these
effects will then reinforce helpers' commitment to the residence, resulting in longer retention. SLHs
are ideal sites for the proposed study because the primary therapeutic influence involves peer support
within an alcohol- and drug-free living environment. Because the current research on the relationship
between helping and recovery focusses on alcohol problems, a current alcohol use disorder will be an
inclusion criterion. The study will include qualitative interviews to inform study procedures and
identify experiences of giving and receiving help that illuminate the path model. Individuals entering
SLHs with alcohol use disorders (N=200) will be assessed on measures of helping, social networks,
substance use, and severity of problems on the ASI. Because the rates of relapse are highest soon after
entering the houses, we will conduct baseline and monthly assessments during the first three months
and a final interview at 6 months. Significance of the study is high because SLHs and other types of
recovery residences are experiencing rapid growth and data are needed on malleable factors that
promote better outcomes. Further, this study will add to the narrowly focused literature on helping in
recovery and will be the first to illustrate the pathways by which helping influences outcomes in SLHs.
SLH providers will be able to use study findings to determine intervention points for enhancing
retention and sustaining recovery among sober living residents.

Public health relevance
Public Health Significance Relapse during recovery from alcohol and drugs is a common occurrence that undermines the improvements individuals make in multiple areas. Persons who relapse are prone to continue using substances and suffer additional consequences, such as psychiatric, legal, medical, and work problems. Although peer helping has been shown to have beneficial effects on alcohol outcomes, very few studies have examined the relative effects of giving and receiving different types of help (e.g., instrumental versus emotional) from different sources (e.g., recovering peers, family, and friends). The proposed study will examine the effects of helping behaviors among a sample of persons residing in peer operated sober living recovery houses (SLHs). Analyses will show the types of helping most strongly associated with sustained recovery and the pathways by which it operates.